Developing a framework for designing the next generation of pediatric ARDS trials

PROJECT SUMMARY
Advancements in the evidence-based care of critically ill children have been limited by recent clinical trials
failing to show definitive statistical benefits across a variety of outcomes. Clinicians at the bedside, however,
often interpret the results of these trials differently, believing the results are not necessarily applicable to their
patient, that the results are equivocal, or that results suggest potential benefit. These differences are partly due
to the currently used frequentist clinical trial design methodology that hypothesizes unrealistically high
treatment efficacy to adequately power trials amongst the limited pool of critically ill children and generate a
binary interpretation of definitively beneficial or not based on these factors. Additionally, the heterogeneity of
treatment effect amongst the critically ill has often been ignored and subgroup analysis fails to fully address
this important consideration. Thus, this proposal aims to compare heterogeneity of treatment effect (HTE)
analysis methodologies in a trial of pediatric ARDS ventilator management. Additionally, the proposed study
would examine the construct validity of commonly employed 28-day composite outcomes to predict late
morbidity and mortality. Finally, Dr. Keim will develop skills necessary to become a clinical trialist through
conducting a feasibility trial comparing positive end-expiratory pressure (PEEP) guided by electrical impedance
tomography (EIT), a non-ionizing, non-invasive imaging tool highlighting lung aeration, to standardized
PEEP/FiO2 table titration. In addition to feasibility data, Bayesian trial simulations will be conducted to enhance
Dr. Keim’s methodological expertise and inform the future definitive trial sample size. Successful completion of
these Aims will propel Dr. Keim towards his career goals of refining the methodology utilized in clinical trials of
critically ill children to (1) improve the assessment of the feasibility of trials, (2) generate more usable and
understandable interpretations for the treating clinician, and (3) highlight methods to understand HTE in clinical
trials and develop trial planning to generate individualized treatment effect (ITE) estimates. The results of the
proposed studies promise to enhance future pediatric ARDS trials by increasing the clinical relevance of trial
outcomes and generating clinically usable probabilistic interpretations that are responsive to the heterogeneity
omnipresent in critical care trials. The principal investigator of this study, Dr. Garrett Keim, is uniquely
positioned to complete the aims of this proposal due to his training in epidemiologic and biostatistical methods
and his research experience investigating morbidity in survivors of pediatric acute respiratory failure.
Supported by his strong mentorship team and research environment, he will leverage the opportunities
presented by this proposal to develop into an independent patient-oriented physician-scientist and clinical
trialist to improve the evidence-based care of critically ill children.

Public health relevance
PROJECT NARRATIVE Heterogeneity of disease, low prevalence, low mortality, and unrealistically optimistic effect sizes have all contributed to the failure of most pediatric critical care trials to show definitive benefits for a variety of outcomes, which has limited evidence-based care for this vulnerable patient population. This project strives to evaluate heterogeneity of treatment effect (HTE) and Bayesian clinical trial methodology in pediatric critical care by comparing HTE analytic methodologies in an ongoing ventilator management trial in pediatric ARDS, further developing the utility of composite outcomes that are frequently used in pediatric ARDS trials, and conducting Bayesian simulations and trial feasibility of electrical impedance tomography-guided positive end expiratory pressure (PEEP) titration compared to standardized PEEP/FiO2 tables. The completion of these aims will provide key elements needed to design Bayesian interventional trials for pediatric ARDS that are adaptive to treatment heterogeneity and the constraints of pediatric critical care.